OUTCOMES OF EXTRACELLULAR VOLUME CHANGES--THE OLDEST OLD

To determine if age-related physiologic changes in the regulation of extracellular fluid homeostasis predispose the elderly to morbid disorders of fluid balance.